Impact of CDKL5 deficiency on thalamocortical dynamics

Project Summary
CDKL5 Deficiency Disorder (CDD) is an X-linked genetic disorder caused by mutations in the cdkl5
(cyclin-dependent kinase-like 5) gene. Patients with CDD exhibit many features common to Autism Spectrum
Disorder, but also frequently suffer from cortical visual impairment. Specifically, patients with CDD display deficits
in visually-evoked potentials, an indirect measure of visually evoked thalamocortical input. Emerging evidence
suggests that loss of CDKL5 is also associated with neuronal hyperexcitability. Together, this suggests that loss
of CDKL5 may shift the balance between thalamocortical and intracortical processing. Mice lacking CDKL5
recapitulate many aspects of human CDD patients, including visual impairment, and also exhibit changes in
arousal. Work from our lab and others has demonstrated that arousal states reflect distinct underlying
physiological processes that influence spontaneous and sensory-evoked neural activity. However, the relative
impact of behavioral state dysregulation on thalamocortical dynamics and the contribution of a shift from
feedforward inputs to intracortical network control on visual processing remains unknown. Leveraging a recently
developed technique from our lab, we can simultaneously monitor spontaneous and visually-evoked thalamic
axon activity in the primary visual cortex and cortical activity across the dorsal neocortex in the awake, behaving
mouse. Using this approach, we have begun to characterize the functional consequences of CDKL5 deficiency
on state-dependent thalamocortical dynamics and visual processing. Our preliminary data demonstrates that
CDKL5 deficient mice display altered arousal states and cortical activity in a sex-dependent manner, along with
increased intracortical functional connectivity. Initial experiments suggest that CDKL5 deficient mice also exhibit
reduced visual response magnitudes in in primary visual cortex. We will therefore test the following hypotheses:
1) dysregulation of behavioral state in CDKL5 deficiency also disrupts thalamocortical network activity; 2) loss of
CDKL5 results in an increase in intracortical connectivity and a decrease in thalamocortical connectivity; 3)
CDKL5 deficiency leads to reduced thalamocortical visual sensitivity; and 4) CDKL5 deficiency decreases
feedforward transformation of sensory information. Together, our results will provide unprecedented insight into
the functional consequences of CDKL5 deficiency for state-dependent thalamocortical networks and visual
processing in a mouse model of CDD.

Public health relevance
Project Narrative CDKL5 deficiency disorder (CDD) is a rare neurodevelopmental condition associated with cortical visual impairment, neuronal hyperexcitability, and dysregulation of arousal states. Using a mouse model of CDD, I will determine the impact of CDKL5 deficiency on state-dependent thalamocortical network dynamics and identify circuit-level mechanisms underlying how loss of CDL5 contributes to altered visual sensitivity. We expect our results to provide insight into the functional consequences of CDKL5 deletion in mice, with a focus on behavioral state modulation of thalamocortical dynamics and the balance between feedforward and intracortical functional connectivity.